HIV and Other Infectious Diseases Clinical Research Support Services (CRSS)

In support of NIAID Division of AIDS (DAIDS) activities, this contract provides a broad range of clinical, laboratory, training and related services to the DAIDS clinical research program. The DAIDS global clinical trial portfolio currently includes over 320 active protocols, 70+ active INDs, 550+ network study sites in 20+ countries as well as collaborations with 60 pharmaceutical companies. This is a requirements-driven, deliverables-based contract. Specific support can be requested in areas including clinical site visits such as assessments, audits, mock inspections; laboratory support to include Good Clinical Laboratory Practice Audits (GCLP); study specific readiness support including document review and translations, ad hoc clinical trial support and clinical research project management support.